Community-Engage?Modeling?and Implementation Science to Develop Re-Linkage Interventions for Black Men who have Sex with Men with HIV

ABSTRACT
Background: Black men who have sex with men (MSM) are disproportionately impacted by HIV and face many barriers to care engagement, such as housing instability, unemployment, and criminal justice involvement. Interventions to address these factors are resource intensive and logistically challenging, and the best implementation strategies remain unclear. Agent-based models (ABMs) can be used to virtually evaluate candidate interventions and implementation strategies to facilitate more efficient and timely intervention development, and combined with iterative community and public health stakeholder feedback can provide important insights about which intervention strategies and implementation levers would be most effective and efficient in real-world settings. Objective: Building on an existing ABM platform, this proposal will utilize multiple existing local data sources and new data collected through qualitative interviews and focus groups to better understand barriers to linkage, engagement, and retention in HIV care among Black MSM. We will combine methods from epidemiology, agent-based modeling, and implementation science to understand the potential impact of strategies to increase engagement and retention in HIV care on population-level HIV transmission. Methods: We will characterize individual, clinical, and system level barriers to engagement and retention in care, identify relevant implementation levers, and use this information to simulate (Phase 1) and pilot (Phase 2) implementation strategies to improve re-linkage, engagement, and retention in care among previously diagnosed individuals who are not consistently engaged in care. Significance: A better understanding of where and how to focus efforts to relink out of care individuals and to improve HIV care engagement and retention has the potential to have an important impact on the HIV epidemic. Once developed, our methods and models can be adapted to other geographic areas to reflect local prevention priorities and can serve as an example application of implementation science and ABM methods to advance HIV prevention science.

Public health relevance
PROJECT NARRATIVE Public Health Significance: This study will address an important scientific gap by improving our understanding of the potential impact of strategies for relinkage to care for out-of-care patients with HIV. This proposal addresses the NIH Office of AIDS Research Priority Area to “Reduce the Incidence of HIV.” The work has the potential to reduce HIV transmission for the most highly impacted populations, consistent with National HIV/AIDS Strategy goals and contributing to national Ending the HIV Epidemic goals.